Electrophysiological Approaches to Understanding Functional Organization of Speech in the Brain

ABSTRACT FROM PARENT R01
To understand speech, the human brain must parse and transform a noisy acoustic signal into meaningful
linguistic content, including phonemes, syllables, words, and sentences. This involves determining the timing of
important acoustic events, such as the onset of a sentence or a phrase. Following detection of these onsets,
the content of the sentence must be determined. The posterior superior temporal gyrus (pSTG)—including the
classic “Wernicke’s area”—is critical to this process, but until recently, little was known about its functional
organization, and in particular how this functional organization changes throughout development. Our recent
work showed that a spatially discrete region of the pSTG is critical for indicating when a sentence or phrase
begins. This region is distinct spatially and functionally from more anterior “sustained” areas that encode
phonetic feature information throughout a sentence. Functionally, both posterior onset and anterior sustained
regions show short and long temporal integration times, respectively, suggesting complimentary roles in
natural speech processing. Here, we propose an innovative approach using rare datasets where neural activity
is recorded directly from the human auditory cortex and speech-related areas in pediatric patient participants
undergoing clinical evaluation for epilepsy surgery. This method overcomes the spatial and temporal resolution
limitations of other noninvasive procedures, and provides a rare window into the function of the human auditory
cortex. The proposed study will use high resolution intracranial recordings to investigate how the brain detects
acoustic onsets in natural speech sound mixtures, and how neurophysiological responses to these sounds
change from early childhood to adolescence. Furthermore, we will investigate how these responses to onsets
are modulated by context, including during attention and for self-generated sounds. In addition to providing
insight into the basic functional organization of the human auditory cortex and cortical mechanisms for auditory
scene analysis, this research has important implications for the development of a speech brain computer
interface. Our results could also inform how speech and language are processed in natural contexts, which has
implications for the treatment of developmental language disorders, auditory processing disorder, dyslexia,
autism, and aphasia.

Public health relevance
PROJECT NARRATIVE (from Parent Proposal) The proposed study will investigate the organization of speech sound representations in the developing brain from childhood to adolescence. In addition to its overall organization for speech, we will determine how the brain is able to segment continuous speech sounds in different contexts, including when speech is self- generated or occurs in the presence of noise or other competing information. Understanding such processes will inform developmental milestones for brain development, and could lead to brain-based treatments of language disorders delayed language learning and dyslexia.